Hemozoin and liver stage malaria vaccine efficacy

Despite being linked to febrile disease nearly 150 years ago, malaria still kills more than 600,000 people each
year; most of those individuals being children under the age of 5 in sub-Saharan Africa. These numbers highlight
the urgent need to develop effective antimalarial vaccines. The plasmodium parasite replicates in an
asymptomatic liver stage followed by the symptomatic blood stage. Our lab and others have found that circulating
(TCIRCM) and liver resident memory (TRM) CD8+ T cells targeting liver stage malarial antigens can facilitate
sterilizing immunity. The gold standard of inducing liver stage protection has long been immunization with
Radiation Attenuated Sporozoites (RAS), which arrest in replication during the asymptomatic liver stage. It has
been demonstrated in murine and human models that RAS immunization can provide sterilizing immunity to
malaria in 100% of subjects. However, this protection drops precipitously in individuals with prior malaria
exposure. Our lab and others have modeled this discrepancy and found that mice with prior malaria exposure
have reduced CD8+ T cell responses to RAS immunization which drives this impaired protection. We have
determined this to be a T cell extrinsic defect, implicating compromised functions of antigen presenting cells
(APCs) as the primary driver of the T cell defect. Unfortunately, the mechanism nor the host and/or parasite-
derived factors mediating this phenotype are unknown. Our long-term goal is to understand the biology that
underlies the impaired CD8+ T cell responses observed in blood stage malaria experienced individuals.
We have identified the blood stage malarial pigment hemozoin (Hz) as a candidate driver of impaired CD8+ T
cell priming, as injection of synthetic Hz phenocopies our findings of CD8+ T cell impairment in plasmodium
experienced mice. Moreover, Hz has been demonstrated to be taken up by APCs and we have found evidence
that it impairs antigen uptake and chemokine-directed migration in these APCs. In Aim 1, we will determine the
effects of Hz on CD8+ T cell priming using innovative approaches including intravital microscopy and scRNAseq.
Importantly, we have designed an mRNA vaccine that elicits equivalent circulating CD8+ T cell responses in
malaria experienced mice and naïve controls. In Aim 2, we will optimize mRNA LNP vaccination strategies to
maximize both TCIRCM and TRM generation and protection in malaria experienced hosts utilizing cutting-edge LNP
targeting strategies and cytokine encoding mRNAs. Finally, yellow fever virus (YFV) co-circulates in malaria
endemic regions. Therefore, the YFV vaccine is recommended for individuals living in these regions. Despite the
established impairment of malaria exposure on vaccine-induced T cell responses, it is unknown how malaria
exposure impacts YFV vaccine efficacy. In Aim 3, we will incorporate a murine model of YFV vaccination to
determine the impact of prior malaria exposure on YFV vaccine responses. The results of this proposal will
provide a mechanistic understanding into CD8+ T cell mediated immunity to arthropodborne pathogens in
malaria exposed individuals and define novel vaccination strategies to maximize immunity.

Public health relevance
PROJECT NARRATIVE: Despite being the gold standard in generating sterilizing immunity against malaria in malaria naïve individuals, Radiation Attenuated Sporozoite (RAS) vaccination is only 30% effective in individuals with prior malaria exposure. The goal for this proposal is to elucidate the mechanisms by which the long-lived malarial pigment hemozoin modulates the generation of effective vaccine-specific CD8+ T cell responses. The outcome of this research will provide the key knowledge necessary to design more effective malaria vaccines.